Metabolic-Purinergic fitness in periodontal health and disease

Project Summary
Despite periodontitis typically manifesting in later stages of life, our understanding of the mediators and
biomarkers linked to severe disease manifestation and hyper-inflammatory responses leading to osteolytic
destruction remains limited. In this context, the role of nucleotide-metabolizing enzymes, such as ecto-5’-
nucleotidase (NT5E), or CD73, in characterizing purinergic influence on inflammatory alveolar bone loss remains
largely unexplored. During the inflammatory process, there is an increase in extracellular ATP (eATP), and CD73
serves as the final step in converting eATP to adenosine (ADO) aiming to restore homeostasis. Our recent
findings have illuminated the critical role of CD73-dependent ADO in controlling inflammation-associated state
in gingival fibroblasts, implicating mitochondrial metabolism as a central mechanism in the pathogenesis of
hyper-inflammatory gingival responses. Furthermore, our research has revealed that CD73-/- mice exhibit more
aggressive alveolar bone loss in a ligature-induced periodontitis model. We observed a heightened
proinflammatory state in murine primary gingival fibroblasts and a more aggressive osteoclast phenotype in mice
lacking CD73 due to their increased mitochondrial activity. Our strong preliminary data have led us to hypothesize
that ectonucleotidase CD73 in fibroblasts directs the metabolic capabilities of a stromal-osteoclast axis, due to
increased migration and retention of osteoclast precursors leading to excessive bone resorption in periodontal
pathogenesis. This hypothesis will be investigated through two Specific Aims: Specific aim 1 will delineate how
CD73 deficiency leads to metabolic dysfunctional inflammation-associated gingival fibroblast state and define
the link to osteoclast hyper-function. Since mitochondrial dysfunction is one of the hallmarks of ageing, age is
incorporated as a biological variable. Specific aim 2 will study whether metabolic dysfunction drives an imbalance
in the purinergic fitness and energy metabolism influencing a stromal-osteoclast axis in periodontium. Sex-
related differences in metabolism of males and females will be considered. This research will lead to a
comprehensive understanding of CD73 function in the periodontium as well as improve our knowledge of
purinergic-metabolic relationship in periodontal health and disease. It will enable us to determine whether CD73
ectonucleotidase can be specifically targeted to manage periodontal homeostasis serving as a potential
candidate for early diagnosis to prevent hyper-inflammatory responses.

Public health relevance
Project Narrative Periodontitis affects millions in the United States and is linked to various systemic diseases, including metabolic disorders. We are studying the function of CD73, an enzyme found in the surface of gingival cells, in regulating metabolic function of bone resorptive cells and the course of periodontitis. By elucidating how CD73 affects the response of gingival and bone cells, we can utilize this information to discover new potential biomarkers for early diagnosis and prevention of periodontitis.